IMSD at Stony Brook University: Maximizing Excellence in Research for Graduate Education -- Fostering Inclusive Research Scientist Training (FIRST)

Project Summary / Abstract IMSD at Stony Brook University: Maximizing Excellence in Research for Graduate Education Fostering Inclusive Research Scientist Training (FIRST) The Fostering Inclusive Research Scientist Training (FIRST) Workshop series (supplement to the NIH-funded Stony Brook University Initiative for Maximizing Student Development: Maximizing Excellence in Research for Graduate Education) is designed to better equip faculty and administrators in biomedical science departments and graduate programs to foster safe and inclusive training environments for underrepresented (UR) trainees in the biomedical sciences. The workshop series will focus mitigating the effects of the “chilly climate”, the phenomenon where UR individuals feel unwelcome in an environment due to factors such as numerical underrepresentation and perceptions of unconscious and/or overt bias. The three main areas that addressed by the workshop series are anti-racism; unconscious bias; and allyship and advocacy - three topics recognized as areas of need by biomedical science trainees at Stony Brook University. The audience for the FIRST Workshop series is faculty and staff with important roles in biomedical science graduate training programs at Stony Brook University. The seven-session FIRST Workshop series will employ a data-driven and evidence based approach to develop curriculum and will employ the EPIC (exposure, persuasion, identification, and commitment) model of active learning (Aragon et al., 2016), utilizing an incremental approach to both successfully convey the importance of the topics and to motivate participants to adopt the practices covered in the material. FIRST Workshop participants will also have the opportunity to develop a specific activity that addresses a workshop topic of their choice and present their plan to all of the workshop participants to obtain suggestions for improvements, discuss their plans for implementation and celebrate the work of all of the participants. The FIRST Workshop will better prepare faculty and staff to create safe and inclusive training environments that diminish the chilly climate and encourage UR trainees to pursue biomedical science career paths.

Public health relevance
Research Training Program Plan IMSD at Stony Brook University: Maximizing Excellence in Research for Graduate Education -- Fostering Inclusive Research Scientist Training (FIRST) Training initiatives like the NIH Initiative for Maximizing Student Development (lMSD) have focused on increasing the number of individuals from underrepresented (UR) backgrounds recruited into biomedical science doctoral programs, developing programs and activities to increase trainee resiliency and retention, and providing the necessary professional development to advance UR trainees onto academic and research career paths. While these activities are critical to increasing the diversity of the biomedical workforce, the key focus has been on preparing UR trainees to overcome the systemic barriers of discrimination and not on mitigating the environmental factors that contribute to UR trainee attrition. Increasing the participation of individuals that have been historically underrepresented in the biomedical sciences is a critical issue (Cohen, 1997; Ferrini-Mundy, 2013; Handelsman et al., 2005; Nivet 2010; Smedley et al., 2004). A diverse biomedical science workforce is crucial to scientific innovation, addressing health disparities, and increasing national competitiveness on the global stage (National Academy of Sciences, National Academy of Engineering, and Institute of Medicine, 2007; National Academies of Sciences, Engineering, and Medicine, 2020). However, trainee-focused efforts do not address one barrier that has been cited as contributing to STEM attrition, the “chilly climate” (Herzig, 2004; Hughes, 2018; NSF, 2004), the phenomenon where UR individuals feel unwelcome in an environment due to factors such as numerical underrepresentation and perceptions of subtle and/or overt bias. To successfully create training environments that will empower UR individuals to succeed, more work must be done to support faculty and staff to address the issues that may contribute to a chilly climate and promote safe and inclusive training environments for trainees from diverse backgrounds. We propose the Fostering Inclusive Research Scientist Training (FIRST) Workshop series to better equip faculty and administrators in biomedical science departments and graduate programs to foster safe and inclusive training environments for UR trainees. The series will focus on three areas that will address the chilly climate: anti-racism; unconscious bias; and allyship and advocacy. These three topics were recognized as areas of need by trainees in the biomedical sciences at Stony Brook University. The audience for the FIRST Workshop series will be faculty and staff with important roles in nine different graduate training programs in the biomedical sciences at Stony Brook University. We will employ a data-driven and evidence based approach to developing the FIRST Workshop curriculum. We will collect data from trainees, faculty, and staff from the participating biomedical science doctoral programs to assess the training program, departmental, and institutional climate as it relates to each of the three FIRST Workshop topics. We will also draw upon the most recent and relevant research in social science and education. The seven-session FIRST Workshop series will employ the EPIC (exposure, persuasion, identification, and commitment) model of active learning (Aragon et al., 2016), utilizing an incremental approach to both successfully convey the importance of the topics and to motivate participants to adopt the practices covered in the material. Each of the three FIRST Workshop topics (anti-racism; unconscious bias; and allyship and advocacy) will be covered in two sessions: the first focusing on exposure to the topic and persuading the audience of its relevance to fostering inclusive training environments (exposure and persuasion); and the second focusing recognizing the concept(s) in the training environments and discussing possible concrete approaches for addressing instances of bias and exclusion in the environment of their training program (identification and commitment). Following the final session of the final topic, faculty and staff participants will organize into groups to work together to develop a specific activity that addresses a workshop topic of their choice. These groups will then come together for a seventh and final session to share these activities, obtain suggestions for improvements, discuss their plans for implementation, and celebrate the work of all of the participants. Project timeline (contingent on award date): ● July - November 2021: Literature review, curriculum development, and development of assessment plan. Assets to be developed for workshops: slide deck, literature review, syllabus and reading list, facilitator training guide, participant workbook, standard evaluation and assessment content. ● January - April 2022: Deployment of workshop series (one Workshop topic with two sessions per month with the final participant group presentations in April) ● May - June 2022: Workshop evaluation and assessment and reporting/dissemination. Personnel: ● Workshop Curriculum Designer, Developer and Educational Expert: Dr. Angel Gonzalez will lead the development and implementation of the workshop. His social science background will ensure curriculum development and assessment administration is data-driven and evidence-based. Dr. Gonzalez was the Program Manager for the previously funded NIH R25 IMSD and has the same role in the currently funded NIH T32 IMSD. The IMSD training program serves as a natural hub, connecting nine biomedical science doctoral programs at Stony Brook University (Chemistry, Biochemistry and Structural Biology, Biomedical Engineering, Ecology and Evolution, Genetics, Microbiology and Immunology, Molecular and Cellular Biology, Neuroscience, and Molecular and Cellular Pharmacology). Thus, Dr. Gonzalez, will be able to leverage the relationships developed through his interactions with the management of these projects to encourage effective faculty and staff participation. ● Content Development Assistant: Julianna Pryor, Administrator of the Center for Inclusive Education, will assist in the development and editing of workshop materials. She worked as the Content and Publications Writer in the Center for two years prior to transitioning into the Administrator role. Her professional experience spans over 14 years, with the most recent seven years focused on diversity, equity and inclusion-related materials disseminated by the Center. ● Program Administrator: Toni Sperzel, co-Investigator of Stony Brook University’s NIH T32 IMSD project and Director of the Center for Inclusive Education at Stony Brook University, will serve as program administrator. As the administrative unit responsible for development and implementation of the IMSD T32 training grant, the Center is the ideal campus unit to administer and host this workshop series. ● Graduate Assistant: A full-time (20 hours per week) Graduate Assistant with a social science or education background will be hired to assist with curriculum development, assessment and coordination. We will recruit a student whose participation in these activities will allow them to gain experience relevant to their intended career path. ● Faculty Collaborators: The FIRST Workshop development team will consult with Dr. Peter Gergen to draw upon his experience as biomedical science faculty and incorporate the perspective of a mentor who has advised UR trainees. Further, as Pl of NIH-funded IMSD T32 at Stony Brook University, Dr. Gergen will leverage his relationship with the other T32 PIs and participating faculty to increase FIRST Workshop awareness and encourage participation. Outcome Assessment: The effectiveness of the FIRST Workshop will be measured through short-term and long-term assessments: ● Short-term assessment: Pre- and post-workshop session surveys will be conducted to measure familiarity with topics, learning, and commitment to utilize skills taught. Surveys will also be conducted at the end of the entire workshop series to evaluate overall satisfaction and obtain feedback to improve upon the workshop for future iterations. ● Long-term assessment: Annual surveys will be administered to participants to assess long-term adoption of the skills and techniques covered in the FIRST Workshop and the success of deploying activities developed through the workshop in their home department. Further, we plan on creating on-going cohorts via communication platforms (Slack, Google Hangouts, etc.) to share successes and challenges, ask for and provide guidance, and ensure that the conversation of promoting safe and inclusive training environments continues beyond workshop participation. Annual surveys will be administered to trainees of participating graduate programs to gauge the climate of their respective program. Program Participants: The FIRST Workshop will better prepare faculty and staff to create safe and inclusive training environments that diminish the chilly climate and encourage UR trainees to pursue biomedical science career paths. We will recruit 18 faculty and staff participants from nine biomedical science graduate programs (Chemistry, Biochemistry and Structural Biology, Biomedical Engineering, Ecology and Evolution, Genetics, Microbiology and Immunology, Molecular and Cellular Biology, Neuroscience, and Molecular and Cellular Pharmacology) and all of the NIH-funded training programs at Stony Brook University. Outcome Dissemination: At the institutional level, if the FIRST Workshops series is demonstrated to be effective, we plan on sharing the outcome data with the Graduate Program Directors of the biomedical science graduate programs and PIs of the NIH-funded training programs to encourage them to incorporate the workshop as part of their training plans. Further, we will work with Stony Brook University’s Vice Provost for Faculty Affairs and Diversity, Equity and Inclusion to advocate for a campus-wide implementation of the workshop to create safe and inclusive environments across departments and disciplines. At the national level, we plan on presenting program outcomes and best practices at national conferences and meetings, partner institution visits, and through electronic publications.